Biology and Immunotherapy of iNKT Cells

Abstract Project 1
Allogeneic hematopoietic cell transplantation has proven to be a life-saving therapy for a broad
range of hematological malignancies, genetic disorders and bone marrow failure states. However,
the immunological consequences of graft vs host disease (GVHD) and in patients with
malignancies, relapse continue to be major obstacles to the successful outcome of patients. In
this Project we will study a rare population of lymphocytes termed invariant natural killer T (iNKT)
cells that have a number of properties that make them highly attractive to address these issues.
iNKT cells express a unique and invariant T cell receptor that recognizes a non-MHC like molecule
CD1d that is expressed on many different hematological malignancies. We have demonstrated
that allogeneic and third party iNKT cells have immunoregulatory properties and are capable of
suppressing GVHD more potently then regulatory T cells. Further, we have demonstrated that
introduction of a CAR into iNKT cells unleashes both direct and indirect mechanisms of cytolytic
function. In this Project we will explore both the immunoregulatory and cytolytic function of iNKT
cells with the goal of developing a fundamental mechanistic understanding of their function and
translating these concepts into early phase clinical trials. This Project interacts with all of the other
Projects and Cores of the Program and aims to develop fundamental new concepts and a clinical
treatment candidate to address GVHD and disease relapse.

Public health relevance
Narrative Project 1 Project 1 will focus on the biology and clinical translation of invariant natural killer T (iNKT) cells that have properties of both immune regulation and cytolytic function. We believe iNKT cells have unique properties that make them ideal for allogeneic ‘off the shelf’ based therapeutics. In this Project we will explore the biology of iNKT cells and translate this concept to the clinic.